Core D: Clinical Core

PROJECT SUMMARY/ABSTRACT
This Clinical Core is specifically designed and supported with the objective of facilitating the translational mission
of the Pacific Northwest (PNW) Prostate Cancer SPORE. Each of the five major projects directly utilizes patient-
derived materials and attendant clinical data, and most are designed with a patient-directed interventional trial.
However, there are major barriers between clinical, basic and population-based research that constrain progress;
thus, the Aims of this Core were formulated to assist the major projects, developmental projects, and career
development awardees in the rapid advancement of their research objectives.
The Clinical Core has the following Specific Aims:
Specific Aim 1: To design, execute, accrue to, and otherwise facilitate the conduct and timely completion of
human clinical trials relevant to SPORE translational science. The Clinical Core will support
major research projects, developmental research studies, and clinical trials related to the
Career Enhancement Program.
Specific Aim 2: To design, direct, and assist with patient recruitment for biospecimen acquisition.
Specific Aim 3: To direct, support, and enhance CAISIS (repository of clinical and patient-reported data) to
support clinical and translational prostate cancer research across the SPORE sites.
Specific Aim 4: To ensure that SPORE Major and Developmental Projects maintain a patient-centered focus,
we will support and engage the SPORE Advocacy Committee in the activities of the SPORE.

Public health relevance
PROJECT NARRATIVE The Clinical Core will carry out the vital objective of supporting and engaging the patient community, who are so vital to the research efforts of the Projects; counsel, enroll, and treat patients on SPORE-related clinical trials; provide support to the rapid autopsy program and the clinical database, CAISIS; and be a resource to the clinical sites of the University of Washington, the University of British Columbia, Oregon Health and Science University, in all aspects of trial design and management.